Career Enhancement Program

CAREER ENHANCEMENT PROGRAM – PROJECT SUMMARY
The goal of the Career Enhancement Program (CEP) is to attract, develop, and monitor the most promising
investigators for translational research in hepatobiliary cancer. To meet these objectives, the aims of the
SPORE CEP are designed to:
 identify the most promising candidates
 emphasize the recruitment of qualified women, minorities, and persons with disabilities
 conduct a thorough evaluation of all applicants
 evaluate and monitor career development and mentoring of CEP awardees
 facilitate extramural funding and integration of awardees into future SPORE projects
The CEP is targeted to both junior faculty and early mid-career faculty at any Mayo Clinic campus who will
commit to mentored career development in translational, multidisciplinary basic, clinical or population-based
hepatobiliary cancer research. Mentoring teams consist of both senior hepatobiliary cancer researchers at
Mayo Clinic together with highly productive investigators in other areas of cancer research. Mentoring is
accompanied by close oversight by the SPORE leadership. The Director of the CEP will report to the SPORE
Director and the SPORE Internal Advisory Board. Mayo Clinic has, by its seamless blend of patient care and
basic and applied research facilities, an environment conducive to this type of mentored translational research.
In that Mayo is highly competitive in recruiting faculty, there is a continuous pool of early, but outstanding,
scientists and clinicians (including talented female and minority investigators) who would benefit by our
SPORE’s proposed CEP to engage in translational research with a focus on hepatobiliary cancer. We have
developed a formal mechanism for recruiting, selecting, and evaluating awardees, and will ensure that
awardees are integrated into the SPORE research environment. The explicit expectation is that the awardees
will utilize the resources made available to them for the development of independent research programs and
acquisition of independent funding in hepatobiliary cancer research. One annual award for up to $100,000 will
be made ($50K from the SPORE grant, matched by Mayo Clinic Cancer Center support).

Public health relevance
CAREER ENHANCEMENT PROGRAM – PROJECT NARRATIVE The Career Enhancement Program will use SPORE and Cancer Center matching funds to provide integrated training and mentorship in the support of one awardee per year. The program seeks to attract both early- or mid-career investigators who are new to hepatobiliary cancer and who will make a career commitment to translational research in this cancer.